Dysregulation of transcription factors and chromatin architecture in Trisomy 21 hematopoietic disorders

PROJECT SUMMARY/ABSTRACT
Human hematopoiesis requires a complex interplay of genes, transcription factors, and epigenetic modifiers that
regulate lineage commitment and maturation. Trisomy 21 (T21), the chromosomal abnormality underlying Down
syndrome, is associated with genome-wide gene dysregulation and baseline hematopoietic abnormalities such
as polycythemia and thrombocytopenia. Transient abnormal myelopoiesis (TAM) and myeloid leukemia of Down
syndrome (ML-DS) are related disorders unique to Down syndrome that arise from a megakaryocyte-erythroid
progenitor with blocked differentiation. TAM and ML-DS are characterized by a megakaryocyte (MK) surface
marker signature and mutations in the hematopoietic transcription factor GATA1, resulting in exclusive
expression of the truncated GATA1s isoform. ML-DS is additionally characterized by “third-hit” mutations in
regulators of epigenetics or chromatin structure, such as in the cohesin complex member STAG2. Individuals
with germline GATA1s mutations without T21 develop cytopenia(s) without leukemic predisposition, emphasizing
the role of chromosome 21-encoded genes, such as the transcription factor RUNX1, in the progression from T21
to TAM to ML-DS. However, the underlying mechanisms remain incompletely understood.
This proposal employs a novel isogenic human induced pluripotent stem cell (iPSC) system to isolate the
individual and synergistic roles of T21, GATA1s, RUNX1 isoforms, and STAG2 loss in hematopoiesis. My data
suggest that T21 and GATA1s synergistically lead to enhanced megakaryopoiesis and cytokine-independent
proliferation, a hallmark of myeloproliferative disorders, and that dysregulation of RUNX1 may contribute to this
phenotype. STAG2 loss combined with T21 and GATA1s further enhances megakaryopoiesis and results in
dysplasia. This proposal builds upon these data through two specific aims: 1) Determine how GATA1s and
RUNX1 co-regulate megakaryopoiesis and 2) Determine how STAG2 loss further perturbs hematopoiesis in
T21/GATA1s cells. The aims seek to produce medically relevant knowledge on normal and Down syndrome
hematopoiesis by combining established and cutting-edge techniques in assessing chromatin architecture, MK
biology, and transcriptional regulation.
This proposal describes a 5-year training plan for the applicant, Dr. Kaoru Takasaki, to transition to an
independent research career in pediatric hematology as a physician-scientist with expertise in the dysregulation
of transcription factors and chromatin structure at the intersection between normal and abnormal hematopoiesis.
She will be supported by two mentors, Dr. Stella Chou, an international expert on hematopoiesis, and Dr.
Mortimer Poncz, a global expert in platelets and MKs, as well as an advisory committee with complementary
expertise in epigenetics, chromatin structure, and iPSC disease modeling. Dr. Takasaki’s research and training
will take place in the resource-rich environments of the Children’s Hospital of Philadelphia and the University of
Pennsylvania that will provide an outstanding foundation to embark on an independent physician-scientist career.

Public health relevance
PROJECT NARRATIVE Infants and children with Down syndrome suffer from a unique constellation of blood diseases, including altered blood counts, myeloproliferative disease, and leukemia. To study how the 3 copies of chromosome 21 and other genetic changes cause these diseases, I use isogenic induced pluripotent stem cells derived from individuals with Down syndrome. My project will provide new insights into blood cell production, identify potential new approaches for the diagnosis and treatment of Down syndrome blood disorders, and elucidate common mechanisms that may underlie other inherited blood diseases.